Endocannabinoid-mediated neuroprotection in models of neuroAIDS in vivo

Project Summary/Abstract
Several neurodegenerative disorders, including Parkinson’s and Alzheimer’s diseases, display alterations in
the function of the endocannabinoid (eCB) system. In the era of combined antiretroviral therapy (cART),
human immunodeficiency virus type 1 (HIV-1) is now considered a chronic disease with an inflammatory
component that specifically targets the brain and causes a high prevalence of HIV-associated neurocognitive
disorders (HAND). The eCB system has attracted interest as a target for treatment of neurodegenerative
disorders, due to the potential neuroprotective, anti-inflammatory, & neurotrophic properties of CBs. However,
therapeutic use of eCBs in vivo is unlikely due to their rapid degradation by catabolic enzymes. The main
enzymes responsible for degradation of two major eCBs, anandamide (AEA) and 2-arochinonoylglycerol (2-
AG), are respectively: fatty acid amide hydrolase (FAAH), and monoacylglycerol lipase (MAGL). A new class of
selective inhibitors of those enzymes has been developed that show neuroprotective and anti-inflammatory
effects in preclinical animal models of neurodegenerative diseases. These new pharmacological tools allow for
selective elevation of eCB signaling, which enables investigation of physiological actions of particular eCBs as
well as reveal therapeutic potential of such precise modulation. The aim of the present study is to unravel the
role of the eCB signaling in neuroprotection against HIV-1 protein toxicity that results in behavioral changes as
a consequence of HAND. To achieve this goal, we plan to use Tat and gp120 transgenic (tg) mice, as well-
established models of neuroAIDS, that will allow us to determine: 1) the neuroprotective effects of eCBs on
prefrontal cortex (PFC)-dependent behavior in vivo, with use of catabolic enzyme inhibition; 2) the mechanisms
underlying protective effects of eCBs in PFC ex vivo; and 3) the effects of chronic eCB catabolic enzyme
inhibitors on neuroinflammation using positron emission tomography (PET) imaging in vivo. We hypothesize
that in the HIV-1 protein tg mouse models, eCB catabolic enzyme inhibitors will show protective effects on
behavior, function, and structure via a CB1R/CB2R-mediated mechanism. In Specific Aim 1, Tat tg mice will be
trained on the operant conditioning Go/No-Go task and eCB enzyme inhibitors will be tested for protective
effects against Tat-induced interference in cognitive function, including a decrease of behavioral inhibition and
increased impulsivity. Moreover, the same animals will undergo electrophysiology studies on PFC pyramidal
neurons ex vivo to establish the effects of eCB enzyme inhibitors on synaptic currents. In Specific Aim 2, we
will conduct behavioral, functional, and morphological imaging studies to determine if eCBs are neuroprotective
in Tat toxicity via a CB1R/CB2R-mediated mechanism ex vivo. In Specific Aim 3, non-invasive longitudinal PET
imaging studies in Tat and gp120 tg mice will investigate the effects of eCB enzyme inhibitors on active
inflammatory processes using the tracer [18F]-PBR111. Understanding the role of the eCB system in neuro-
AIDS may uncover novel therapeutic targets for HAND and other diseases in which cognitive deficits occur.

Public health relevance
Project Narrative The neurocognitive impairments associated with HIV-1 infection are associated with chronic neuroinflammation, neuronal degeneration, and defects in synaptic activity. Modulating function of the endogenous cannabinoids emerges as promising therapeutic target in several neurodegenerative diseases due to their anti-oxidative, anti-excitotoxic, and anti-inflammatory properties. This proposal focuses on in vivo and ex vivo approaches to determine the neuroprotective role of the endocannabinoid system in a model of neuroAIDS and strategies to manipulate it for therapeutic benefit.